SYNTHESIS OF TUMOR INHIBITORY COMPOUNDS

This proposal is directed toward the synthesis of cembranoid natural products, a class of compounds whose chemistry and biological activity have been little studied. The specific objectives, isolobophytolide, anisomelic acid, asperdiol and peunicin are cytotoxic and may exhibit antimicrobial, antiprotazoal, and cardiosvascular activity. A major objective is the development of reliable synthetic routes to this widespread class of macro carbocyclic natural products. Of particular interest is the assemblage of multifunctional chiral intermediates suitable for cyclization to the characteristic 14-membered cembranoid macrocycle. Biological testing of synthetic intermediates will be arranged with the appropriate N.I.H. division.